Optimization of an in vivo base editing strategy to treat SOD1-linked ALS

PROJECT SUMMARY
Amyotrophic lateral sclerosis (ALS) is a rapidly progressive, paralytic, and ultimately fatal disease that can be
caused by gain-of-function mutations in superoxide dismutase 1 (SOD1). Despite its severity, there remains no
cure for ALS and current therapies provide only modest beneﬁt to patients, underscoring the critical need for
new, effective strategies for the disorder.
We have developed an approach to inactivate the production of the mutant SOD1 protein in vivo using
CRISPR base editing, a gene-editing modality capable of introducing precise single-base substitutions in DNA,
but without the requirement for a mutagenic DNA break, thus overcoming a major safety hurdle facing the
implementation of traditional CRISPR nuclease-based gene-editors. Through the support of the CREATE Bio
Optimization Track, we have undertaken a milestone-driven research plan that has enabled us to reﬁne not
only the editing capabilities but also the speciﬁcity and tolerability of our SOD1-targeting CRISPR gene
therapy.
As a next step in this project, we will determine the properties of a new SOD1-targeting platform in a non-
human primate, which, compared to most pre-clinical animal models, has greater anatomical, physiological,
and immunological similarities with humans. However, a worsening shortage of NHPs, alongside increases in
their demand for research, has resulted in unanticipated and hefty cost increases for an already limited
domestic supply. To this end, this Administrative Supplement will contribute to: (1) the acquisition of three
rhesus macaques, (2) their intrathecal dosing with an adeno-associated virus (AAV) vector formulation
encoding a new, thoroughly optimized CRISPR-based gene therapy with increased safety, (3) their housing,
and (4) the isolation of nervous system tissue and peripheral tissues. This Supplement will thus ensure that our
study not only carries sufﬁcient statistical power to most accurately quantify the effects for our therapeutic
agent but that it also can be compared to a previously benchmarked version of our technology. As such, this
Supplement is critical to the completion of the milestone goals for the project, “Optimization of an in vivo base
editing strategy to treat SOD1-linked ALS” (5U01NS122102).
In sum, by providing a means to increase the statistical power of our study to most accurately quantify the
efﬁcacy, tolerability, and immunological responses of a novel CRISPR gene therapy, this Administrative
Supplement will ensure that our project exerts a maximum impact in the ﬁeld of ALS therapeutics development
and the ﬁeld of gene therapy at large.

Public health relevance
PROJECT NARRATIVE The goal of this Administrative Supplement is to support the acquisition of non-human primates for their use in determining the efﬁcacy and tolerability of an optimized CRISPR-based gene therapy for amyotrophic lateral sclerosis (ALS). This Supplement will ensure that our project carries sufﬁcient statistical power to most effectively quantify the properties of our agent and to ensure that our new, optimized agent can be compared to a previously benchmarked version of the technology. Thus, this Administrative Supplement is critical for completing the goals of the project, “Optimization of an in vivo base editing strategy to treat SOD1-linked ALS” (5U01NS122102).